Pathological Mechanisms of Immune-Mediated Cerebellar Ataxia with Associated Sez6L2 Autoantibodies

Project Summary/Abstract
Sez6L2 autoantibodies have been reported in patients with subacute cerebellar ataxia.
Patients present with gait ataxia, slurred speech, and ocular motor symptoms. Some patients also
develop limb ataxia, cognitive deficits, bradykinesia, and/or Parkinsonism. These case studies have
led to the hypothesis that autoimmunity against Sez6L2 can directly cause cerebellar damage leading
to ataxia. Sez6L2 is a transmembrane protein expressed by most neurons in the brain including
Purkinje cells and granule cells of the cerebellum. Currently, no animal studies have been performed
to help understand if Sez6L2 autoantibodies are directly pathologic, whether they are a biomarker of
cell-based autoimmunity to Sez6L2, or whether are simply superfluous to the cerebellar pathology.
We plan to test two mouse models of Sez6L2 autoimmunity in order to understand the mechanisms
underlying cerebellar ataxia with associated Sez6L2 autoantibodies. Aim 1 of this project will
determine whether mice immunized with Sez6L2 protein develop cerebellar ataxia. We will also seek to
understand the disease mechanisms using behavioral assessments, immunohistochemistry, and flow
cytometry analysis of infiltrating immune cell populations. Aim 2 will determine whether Sez6L2
antibodies alone can cause cerebellar ataxia in mice, or block Sez6L2’s complement inhibitory functions
in vitro. We anticipate that these studies will provide strong mechanistic evidence that the antibody
and/or full immune response to Sez6L2 is a pathological cause of ataxia and related symptoms. These
studies, coupled with the presently reported human case studies, should encourage prompt and routine
screening for Sez6L2 autoantibodies in suspected immune-mediated presentations of cerebellar ataxia.
The results on disease mechanisms could also help guide clinicians to the immunotherapies that may
be most effective for patients and help justify the risks of prolonged immunosuppression.

Public health relevance
Project Narrative When the immune system mistakenly attacks the cerebellum, the brain region responsible for coordinating movement, it can lead to symptoms of ataxia such as stumbling, falling, incoordination, and slurred speech. This project uses mouse models to understand how the immune system specifically damages the cerebellum when antibodies targeting a protein called Sez6L2 are present. We anticipate the results from these studies will guide physicians to currently available therapies or novel therapies that will best suppress the immune system to protect the cerebellum against autoimmune attacks linked to Sez6L2.